EFFECT OF ACE INHIBITION ON SYMPATHETIC ACTIVITY

Address ACEI on sympathetic function in a definitive way by simultaneous measurements of muscle sympathetic nerve traffic and both systemic and regional norepinephrine release, with methodology recently established.